Data Science Core

Project Summary – Montana INBRE Data Science Core
Community health and biomedical research depend on local capacities to rapidly generate, analyze, and
disseminate information emerging from large and complex datasets. The MT INBRE Data Science Core (DSC)
will provide technical support and facilitate access to resources necessary to ensure researchers across the
MT INBRE network can employ leading-edge computation, cloud, and data collection and management
strategies, including those for community data. The DSC also will provide increased experiential training
opportunities for students. Training efforts will be aligned with Data Science (DS) programs at Montana
Technical University (MT Tech), Montana State University Bozeman (MSU), and the University of Montana
(UM), while responding to self-identified needs across the state through on-site and remote train-the-trainer
workshops for primarily undergraduate institution (PUI) and Tribal college (TC) faculty.
The efforts and direction of the DSC will be guided by four Aims: Specific Aim 1. Position Montana faculty
and students to be leaders in computational science, big data analysis, and artificial intelligence by improving
infrastructure and access to resources. Specific Aim 2. Expand capacity for the collection and application of
community data geared toward improving the health of rural, urban, and native Montanans. Specific Aim 3.
Build regional data science expertise by providing experiential training opportunities to students and faculty.
Specific Aim 4. Contribute to Western IDeA regional efforts to develop data science expertise and capacity
throughout the RAIN network.
A strength of the MT INBRE DSC is the experience to support research projects with community and social
science elements throughout the state while collaborating with the training efforts of the Regional Alliance of
INBRE Networks (RAIN) to take advantage of regional resources and enhance network diversity.